Administrative Core

Administrative Core Project Summary
The goal of the Administrative Core is to strengthen our Center for Research in Human
Movement Variability as a sustainable interdisciplinary research center at the University of
Nebraska at Omaha with national and international recognition. We combine comprehensive
mentoring, strategies for faculty development, and an innovative pilot project program along with
strategic planning and comprehensive evaluation. The Administrative Core aims to (1) provide
fiscal and administrative management for all components of our center, (2) enhance the ability
of the center’s investigators to obtain peer-reviewed grants and launch long-term academic
research careers in human movement variability to treat and prevent motor related disorders
through intensive mentoring, access to our research cores, and expanded opportunities for
research support, (3) continue and enhance our successful pilot project program to attract new
investigators in the center and empower them to generate sound preliminary data and provide
access to our research cores in order to obtain extramural research grants, (4) provide
leadership for success and sustainability of the center, and (5) strengthen our evaluation
program in order to identify and implement improvements for strengthening our Center.